DIOL DEHYDRATASE AND DIOL METABOLISM IN CLOSTRIDIUM GLYCOLICUM

The oxygen sensitive and membrane bound diol dehydratase from Clostridium glycolicum was solubilized from its matrix by sonication of crude membrane preparations anaerobically in 0.1 M CHES buffer, pH 8.5 or 9.0, containing 2 mM dithiothreitol. Treatment with organic solvents, a variety of ionic and nonionic detergents, high ionic strength, or phospholipase A did not solubilize any diol dehydratase activity. Addition of 30% dimethylsulfoxide and 0.15 mg/ml of lysophosphatidylcholine to the CHES buffer before sonication markedly increased recovery of enzyme activity. Up to 45% of the activity could be recovered after centrifugation for 1 h at 105,000 x g. This solubilization method was also shown to work for the membrane bound formate dehydrogenase from E. coli. More than 95% of the activity was recovered in the supernatant after sonication and centrifugation.